Novel antiviral agents targeting early stage CMV replication

Summary:
Human cytomegalovirus (CMV) is a β-herpes virus with high seroprevalence rates of 60-90% within the
population that can spread through bodily fluids, organ transplants, and from mother to fetus via the placenta.
Virus proliferation significantly increases the morbidity and mortality of immunocompromised individuals, such
as newborns, organ transplant recipients, AIDS patients, and the elderly. Approximately 30,000 solid organ
transplant and 23,000 bone marrow transplants operations are performed in the U.S. every year. CMV is the
leading cause of birth defects, affecting ~1% of newborns giving rise to ~30,000 new cases of CMV infection
reported annually in the US. While several drugs have been approved by the FDA for the treatment of CMV
infections, including ganciclovir, foscarnet, letermovir, and recently maribavir, these compounds were found to
exhibit high frequencies of drug resistance and severe side effects, including bone marrow toxicity,
gastrointestinal disruption, and nephrotoxicity. Given the large number of patient populations at risk for CMV-
associated diseases and the estimated cost to treat CMV in the US ($4.4 billion/year by the National Academy
of Sciences), novel therapeutic strategies to treat CMV-associated diseases is needed. The development of
novel therapeutics that target different steps of the viral life cycle to limit virus propagation and spread would
provide therapeutic for treating CMV-related diseases. We developed a high-content screening assay using a
CMV AD169 reporter virus to screen >112,000 compounds with Microbiotix to identify inhibitors that block the
early stage of infection. One compound, MBXC-4302, is a N-arylpyrimidinamine (NAPA) that exhibited potent
anti-CMV infection activity (IC50 ~3 µM), limited cytotoxicity (CC50 >100µM), favorable in vitro ADME properties,
and a responsive structure activity relationship (SAR). The preliminary SAR analysis identified the analogs with
an improved selective index. Our general hypothesis is that the NAPA compounds represent novel CMV entry
inhibitors which can be developed into effective novel CMV therapeutics to prevent virus proliferation and spread.
To evaluate our hypothesis, we plan to complete the following Aims: 1) Characterize the mechanism of action
and target of NAPA compounds; 2) Optimize the NAPA series through SAR-driven analog generation; 3)
Evaluate NAPA compounds to limit virus proliferation using in vitro models; and 4) Evaluate pharmacokinetics,
tolerability, and efficacy of prioritized NAPA analogs in proliferation studies in vivo We plan to develop 1-2 lead
NAPA analogs as effective CMV therapeutics that inhibit CMV dissemination as monotherapy or combination
therapy with FDA approved CMV drugs to prevent virus-associated diseases by limiting viral load.

Public health relevance
Narrative: Human cytomegalovirus causes a high-rate of morbidity and mortality in newborns, transplant recipients, and other immunocompromised individuals including AIDS patients, and patients with cardiovascular disease and autoimmune diseases. The development of CMV therapeutics effective therapeutics will prevent and treat cytomegalovirus-associated diseases.